In-Vivo Monitoring of Therapeutic Drug Transport Across Biological Barriers

Project Summary
The ability of therapeutic drugs to access specific organs strongly depends on the nature of the blood-tissue
barrier at said organs. The prostate and brain, for example, have tight barriers with no intercellular gaps, and
most drugs cannot permeate them at sufficiently high levels to be therapeutically effective. Thus, understanding
the relationships between drug chemical structure, dosing regimen, and organ penetration is crucial to
the development of new and effective drug therapies. Motivated by this, the long-term goal of this program
is to establish a measurement standard of molecular transport parameters affecting the passage of therapeutic
agents across biological barriers in vivo. Specifically, the objective of this proposal is to demonstrate that
electrochemical, aptamer-based (E-AB) sensors – an emerging sensing platform with the ability to continuously
measure the levels of specific molecules in the body – can support continuous monitoring of molecular transport
from blood to liver, prostate and brain. The proposed measurements will determine the transport parameters of
seven therapeutic agents (three aminoglycoside, three β-lactam and one glycopeptide antibiotics) across four
biological barriers (i.e., blood-liver, blood-prostate, blood-brain and blood-cerebrospinal fluid). These drugs were
chosen because, although effective at treating infections across organ barriers, they cause dangerous side
effects driven by their narrow therapeutic window, making their precise dosing an important medical challenge.
The central hypothesis of this work is that achieving spatially and temporally resolved drug measurements in
blood and target organs will produce unprecedented permeability data that will guide new therapeutic drug
development toward the creation of permeability-enhanced therapeutics and more effective dosing regimens.
This hypothesis will be tested by pursuing three specific aims: 1) Determine the kinetics of drug uptake in the
liver via continuous, seconds-resolved E-AB measurements; 2) Determine the transport kinetics of antibiotics
through the prostatic barrier; and 3) Determine the transport kinetics of prophylaxis antibiotics delivered from
blood to the brain. The proposed research is significant because it will define the structural and transport
characteristics necessary for therapeutic agents to penetrate targeted organs and propel the study of other
therapeutics beyond the families of antibiotics considered here. Thus, this work will develop foundational
knowledge and generate the necessary resources for other researchers and industries – working on drug
development, in-vivo testing and clinical dose scaling – to advance the field of therapeutics. The proposed
research will have an immediate positive impact as it will establish a better understanding of therapeutic drug
transport within compartments in the body. Longer term, this work will have established the groundwork
necessary for the in-vivo evaluation of molecular transport across tight biological barriers.

Public health relevance
Project Narrative The direct measurement of molecular transport across biological barriers like the blood-brain or blood- cerebrospinal fluid barriers in vivo would significantly expand our understanding of how therapeutics reach target organs. Moreover, it would enable the determination of important chemical structure and transport relationships to guide early stages of therapeutic drug development. Thus, motivated to obtain a comprehensive molecular understanding of drug transport across biological barriers, our work will deploy the emerging electrochemical aptamer-base sensing technology to determine with high precision the drug transport parameters of seven therapeutics across three different biological barriers.